NEUROGENETICS OF SEROTONIN IN DEPRESSION

Purpose of Study (Succinct summary of what is to be learned): We plan to study the genetics of the serotonin neurotransmitter system comparing genetics of subjects with blunted response to Clomiprmine (CMI) Challenge Testing with subjects who have normal response to CMI testing.